IGF and IGF Receptor Function in Mammary Development

DESCRIPTION (provided by applicant): The IGF ligands, IGF-I and IGF-II, and the IGF type I receptor (IGF-IR) have demonstrated roles in growth of mammary epithelium during normal development. Moreover, the IGFs and IGF-IR promote proliferation of breast cancer cells and are implicated in incidence and growth of breast cancers. Our previous studies demonstrated that IGF-I and IGF-II are distinctly expressed during pubertal and pregnancy-induced development of the mammary epithelium. During the previous funding period, we demonstrated that IGF-I regulates cell cycle progression in mammary epithelial cells and showed unique roles for IGF-I expressed in epithelial and stromal compartments of the developing mammary gland. We further elucidated how patterning of IGF-II expression is regulated in the mammary epithelium. Recent data suggest that the IGF ligands can signal through heterodimers of the IGF-IR and the insulin receptor (IR) in addition to homodimers of the IGF-IR. Moreover, a splice variant of the IR known as the IR-A isoform, has high specificity for IGF-II but not IGF-I. Our preliminary data show that mammary specific deletion of the IR during alveolar differentiation results in significant disruption of alveolar development and lactation. Furthermore, analysis of receptor expression suggests that the ratio of the two IR isoforms varies in mammary epithelial cells during pregnancy and lactation and that a significant portion of the IGF-IR exists as a hybrid receptor with the IR in mammary epithelial cells. Thus, the goal of the experiments proposed in this application is to test the hypothesis that the different IGF signaling receptors have distinct functions in alveolar differentiation and lactation. To test this hypothesis, we propose both in vitro experiments and in vivo transgenic studies to activate or disrupt signaling through the IRs, IGF-IR and hybrid receptors in mammary epithelial cells.

Public health relevance
Public Health Relevance Statement: The results of the proposed experiments will elucidate IGF receptor-specific actions and downstream signaling pathways in proliferation, survival and differentiation of normal mammary epithelial cells. These studies will also have important implications for the roles of these receptors and pathways in breast cancers. __SpecificAimsTextDelimiter__ Research Plan a. Specific Aims The long-term goal of this project is to elucidate how the IGF ligands and their receptors mediate growth of the mammary gland and to determine how their function in normal tissue is related to their role in breast cancer. The IGF ligands, IGF-I and IGF-II, and the IGF type I receptor (IGF-IR) are essential mediators of normal mammary epithelial development in vivo and have been implicated in the development and progression of breast tumors in humans. During the past several years, data from our own and other laboratories provided the basis for our understanding of the role of IGFs in mammary epithelial growth. These data include the demonstration that: 1) IGF-I is essential for initial outgrowth of mammary epithelium into the fat pad during puberty [1], 2) IGF-I regulates cell cycle progression in mammary epithelial cells in coordination with EGF- related ligands [2] (Stull et al., 2002, http://www.ncbi.nlm.nih.gov/entrez/query.fcgi?), 3) the IGF-IR is essential in epithelial cells for normal pubertal ductal development [3], 4) IGF-I and IGF-II have distinct patterns of expression and are differentially regulated during mammary development [4-8] (Richert & Wood, 1999, http://www.ncbi.nlm.nih.gov/entrez/query.fcgi?), 5) IGF-II is expressed in a nonuniform pattern in mammary epithelium downstream of the prolactin receptor and regulated by the transcription factor C/EBPβ [6-8] (Grimm et al., 2003, http://www.ncbi.nlm.nih.gov/entrez/query.fcgi?), and 6) epithelial and stromally expressed IGF-I have distinct functions in postnatal mammary development [9] (Loladze et al., 2006, http://www.ncbi.nlm.nih.gov/entrez/query.fcgi?). The results of these studies demonstrate essential and complex roles for the IGF ligands and receptors in proliferation, ductal outgrowth, ductal branching, and alveolar development of mammary epithelium. However, there remain significant questions concerning the mechanisms and signaling pathways by which the IGFs and receptors promote growth of mammary epithelium. Recent studies have demonstrated the existence of IGF-IR/insulin hybrid receptors (Hybrid-Rs), which show preferential affinity for the IGFs versus insulin [10]. Moreover, IGF-II binds to a splice variant of the insulin receptor (IR) known as the IR-A isoform that has low affinity for IGF-I [11] and is increased in developing tissues and in certain types of cancers including breast cancers [12]. The existence of an IGF- sensitive hybrid receptor and of an IGF-II-sensitive IR isoform raises exciting possibilities for receptor specific actions in mammary epithelial cells and breast cancer cells. Thus, the immediate goal of this application is to determine the function of the IGF signaling receptors in proliferation, differentiation and survival of mammary epithelium. Preliminary data presented here show that 1) expression of a dominant-negative mutant of the IGF- IR (which inhibits both IR and IGF-IR actions) in mammary epithelium impairs both virgin epithelial growth and alveolar differentiation, 2) cre-lox deletion of the IR results in impaired alveolar formation and lactation, 3) the levels of the IGF-IR and ratio of IR-A:IR-B expression vary during specific stages of mammary development, and 4) IGF-IR:IR Hybrid-Rs are present in mammary epithelial cells in vitro and in vivo. The goal of the experiments proposed in this application is to test the hypothesis that the different IGF signaling receptors have distinct functions during postnatal mammary development. We propose three specific aims to test this hypothesis that utilize in vivo genetic approaches and in vitro manipulations to demonstrate that: 1) Both the IGF-IR and IR are essential for alveolar development and for normal lactation, 2) Hybrid-Rs are present and have a distinct function in mammary epithelial cells, and 3) IR-A and IR-B isoforms are developmentally regulated and have distinct roles in alveolar development and lactation.